High-Throughput Studies of MYH7 Variant Cardiomyocytes to Identify Pathogenic Variants and Factors Governing Variable Expressivity of Hypertrophic Cardiomyopathy

PROJECT SUMMARY / ABSTRACT
Hypertrophic cardiomyopathy (HCM), characterized by unexplained left ventricular hypertrophy, affects 1:200-
500 people. HCM can cause heart failure and sudden cardiac death. Pathogenic single nucleotide variants
(SNVs) causing missense substitutions in myosin heavy chain 7 (MYH7; encoding β-MHC) account for 35% of
inherited HCM cases. Pathogenic MYH7 variants are clinically actionable because they identify patients at risk
of developing HCM, prompting early interventions that can prevent sudden cardiac death. However, 75% of
MYH7 missense variants are of unknown significance (VUS) because there is insufficient evidence to determine
pathogenicity. Furthermore, variable expressivity, or symptomatic severity, in patients with pathogenic MYH7
variants limits their prognostic value. Identification of HCM-modifying factors would enable clinicians to
personalize patient counselling. The goal of this proposal is to establish a new system to accelerate MYH7
VUS reclassification and determine the role of putative HCM-modifiers using high-throughput in vitro models
to provide clinically actionable information for patients with MYH7 variants. Human induced pluripotent
stem cells (hiPSCs) retain their donor’s genetic background, can be differentiated to cardiomyocytes (hiPSC-
CMs), and are an ideal model for MYH7 variant effect studies. hiPSC-CMs with pathogenic MYH7 variants have
shown decreased survival, decreased variant-to-wildtype β-MHC protein, and increased atrial natriuretic peptide
(ANP) expression, which correlate with measures of HCM severity. During my postdoctoral training, I developed
a novel gene-editing tool to enable pooled generation of MYH7 variant hiPSC libraries. High-throughput
assessments of a pilot MYH7 variant library in hiPSC-CMs correctly segregated all pathogenic and benign
variants, showing that my approach can be scaled to determine the functional effect of thousands of MYH7
SNVs in hiPSC-CMs (Aim 1). These functional data will aid in the reclassification of up to 140 VUS, yet HCM
expressivity is variable and the roles of putative HCM-modifiers remain largely untested. Genome-wide
association studies (GWAS) have linked many single nucleotide polymorphisms (SNPs) with HCM. I hypothesize
that these GWAS SNPs act as genetic modifiers that drive the expressivity of pathogenic MYH7 HCM variants.
To test this hypothesis, I propose to measure the phenotypic variability of pathogenic MYH7 variants in
hiPSC-CMs generated in an isogenic hiPSC background with three different HCM-associated SNPs
separately introduced (Aim 2). Moreover, males manifest HCM earlier than females and have increased
expressivity after puberty, however, the source of this sex difference remains unknown. I hypothesize that both
sex chromosomes and sex hormones contribute to HCM sexual dimorphism. To test this hypothesis, I propose
to establish a co-culture ‘village’ of pooled MYH7 variant hiPSC-CMs generated on healthy XX and XY
hiPSC backgrounds and examine phenotypic variability with and without sex hormones (Aim 3).

Public health relevance
PROJECT NARRATIVE Hypertrophic cardiomyopathy (HCM) is a devastating disease caused largely by pathogenic variants in MYH7, a clinically actionable gene, yet 75% of reported variants are of unknown significance (VUS). In this proposal, I will establish a new paradigm to accelerate MYH7 VUS reclassification, bringing hope to patients (and clinicians) waiting for an answer. In addition, I will also determine the role of putative HCM-modifying factors in diverse genetic backgrounds to provide clinicians with novel, independent metrics of risk that will enable better HCM risk assessment and counselling for patients.